Regulation of cytokinesis

Summary of the parent funded grant. Cytokinesis, the physical separation of one cell into two
daughter cells, is the final stage of cell division, and although it is the least well understood, it is
central to development and tissue homeostasis. Correctly timing cytokinesis so that it occurs
only after chromosome replication and segregation is necessary to prevent catastrophic
genomic instability, and accordingly, cytokinesis is strictly regulated in concert with other cell
cycle events. Using a powerful model organism, the fission yeast Schizosaccharomyces pombe,
my lab has conducted pioneering research to identify proteins essential for cytokinesis and to
learn how the myriad proteins that comprise the cell division machinery are coordinated to
ensure the exquisite spatial and temporal control of cell division. We propose to continue our
work pursuing fundamental questions in this field using a multi-disciplinary approach in two
directions. In one direction, we will tackle how cytokinesis is entrained with other events of
mitosis by investigating the defect that leads to inhibition of cytokinesis when the mitotic spindle
is disrupted and how the CK1 enzymes that regulate this branch of the mitotic checkpoint are
activated by spindle stress. Understanding CK1 regulation in the context of the mitotic
checkpoint will also establish general mechanisms of regulation for this enzyme family, which
are conserved, multifunctional kinases with roles in numerous human diseases. In a second
direction, we will advance our understanding of the assembly and architecture of the contractile
ring using sophisticated microscopy approaches. We will continue to build our knowledge of the
major scaffold of the contractile ring, the F-BAR protein Cdc15, by defining how it oligomerizes
on the plasma membrane, and how other contractile ring components are organized on the
Cdc15 scaffold. We will also test our hypothesis that 14-3-3 proteins inhibit the establishment of
the Cdc15 scaffold at inappropriate locations and times, ensuring it only assembles in the cell
middle during mitosis. These focused mechanistic studies will be complemented with proteomic
and large-scale genetic screens designed to establish a functional interaction network of
contractile ring components. Together, these studies will have a major impact for understanding
how cytokinesis is orchestrated in eukaryotic species from yeast to humans.

Public health relevance
Narrative Cytokinesis, the physical division of one cell into two daughter cells, is a highly conserved process central to development and tissue maintenance. Cytokinesis is tightly regulated so that it occurs only after chromosome replication and segregation to prevent catastrophic genomic instability and cell death. The goal of the Gould lab is to advance understanding of how the molecules essential for successful cytokinesis are assembled into an actin- and myosin-based macromolecular structure that anchors to the plasma membrane at the correct time and place to divide the cell with exquisite precision.